SCREENING OF INVESTIGATIONAL AGENTS THROUGH THE NINDS PRECLINICAL SCREENING PLATFORM FOR PAIN (PSPP)

The Helping to End Addiction Long-term® Initiative, or NIH HEAL Initiative®, is an ambitious, high-priority effort across the National Institutes of Health (NIH) to speed scientific solutions to stem the opioid public health crisis and better manage chronic pain conditions. NIMH plays a major role in the initiative by leading research examining how to treat people affected by both opioid use disorder and mental illnesses.

Within the NIH HEAL Initiative®, the National Institute of Neurological Disorders and Stroke (NINDS) created the Preclinical Screening Platform for Pain to (PSPP) identify and profile non-addictive therapeutics (small molecules, biologics, devices, or natural products) for acute and chronic pain.

The PSPP is an efficient, rigorous, one-stop screening resource to accelerate discovery of effective, non-addictive pain therapies. The program offers testing, including an assessment of in vitro and pharmacokinetic profiles, side effect profiles, abuse liability, and efficacy in models relevant to human pain conditions.

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”